Dynamics of Eukaryotic Ribosomal Scanning

Regulated protein synthesis, or translation, is essential for life, and allows the cell to flexibly respond to external
stimuli and stress. Conversely, dysregulated translation is a hallmark of diseases including cancer, viral infection,
and developmental disorders. Translation is regulated principally through its initiation phase, where a crucial
regulatory function of the initiation machinery is to ensure selection of the correct translation start site on
messenger RNA. Failure to do so compromises the proteome by permitting synthesis of elongated, truncated,
or nonsense proteins. In eukaryotes, start-site selection requires a directional search beginning at the 5’ end of
the message. This search must move the megadalton ribosomal pre-initiation complex (PIC) efficiently through
mRNA leader sequences that can span tens, hundreds, or even over a thousand nucleotides, and then halt this
motion at exactly the correct start site. A linear “scanning” mechanism was first proposed over 40 years ago for
this remarkable biophysical feat. However, fundamental properties of scanning have never been directly
validated experimentally, and alternative mechanisms have been proposed. The importance of motion through
the mRNA leader in translational control has also been brought into renewed sharp focus in recent years with
the discovery that many mRNAs contain upstream open reading frames in their leaders that control translation
of the main open reading frame; the scanning mechanism lies at the heart of how these are utilized. A critical
barrier to progress is the remarkable molecular complexity and dynamism of the scanning machinery, whose
numerous transient intermediates have made it challenging to characterize experimentally. Directly visualizing
scanning in real time would allow many key unsolved questions to be addressed. Single-molecule methods are
uniquely positioned to do this with the molecular resolution required to dissect mechanism. We have developed
a single-molecule fluorescence assay for scanning of a reconstituted yeast PIC on full-length mRNAs. Here we
will apply this assay to address the scanning mechanism. In Aim 1 we will directly determine the physical
mechanism of motion in scanning, establishing the contributions of mRNA sequence and structure to the
scanning rate. In Aim 2, we will elucidate how scanning directionality is established and maintained, focusing on
the central translational helicase, eIF4A. We will distinguish between proposed mechanisms for how eIF4A
transduces the chemical potential of ATP to bias scanning direction. In Aim 3, we will define the roles of pre-
initiation complex components in scanning, with experiments that isolate their contribution to scanning
specifically, rather than their aggregate functions throughout initiation. These studies will establish a physical-
mechanistic model for scanning that will deepen understanding of translational control in health, and inform
ongoing efforts to understand and reverse dysregulation in disease.

Public health relevance
Scanning plays a crucial role in defining and maintaining the integrity of the proteome, but it remains one of the least-well understood components of regulated protein synthesis. By directly observing scanning dynamics on single messenger RNAs, we will establish a quantitative molecular mechanistic framework that deepens our understanding of scanning and aids efforts to understand and reverse how it is dysregulated in disease.